FEASIBILITY OF FLUCONAZOLE FOR RELAPSE OF HISTOPLASMOSIS IN PATIENTS WITH AIDS

This pilot study seeks to determine the feasibility of fluconazole for induction treatment and suppression of relapse of histoplasmosis in patients with the Acquired Immunodeficiency Syndrome.